Molecular and Functional Characterization of Transcriptionally Defined Subpopulations of VTA Dopamine Neurons

PROJECT SUMMARY
Substance use disorder is a complex neurobiological disease characterized by a loss of control over drug-taking
and drug-seeking behaviors. Further exacerbated by the COVID-19 pandemic, the rate of drug-related
overdoses and subsequent deaths has increased dramatically over the past decade, surpassing 107,000 in
2022. All drugs of abuse increase dopamine (DA) transmission within the nucleus accumbens (NAc) from DA
projections from the ventral tegmental area (VTA). While the presence of tyrosine hydroxylase (Th) has long
been used to identify DA neurons, more recent studies have revealed remarkable heterogeneity among VTA DA
neurons, with some neurons co-expressing markers for both DA and glutamate (Glut) transmission that are
similarly Th+. However, the role of DA-only compared to combinatorial cells in substance use disorder is currently
unknown. Using single nucleus RNA sequencing to comprehensively profile the VTA, we previously identified
unique markers for these two subpopulations of DA neurons. Slc26a7, a gene that encodes an anion transporter,
serves as a selective marker for combinatorial neurons that harbor expression of genes implicated in both Glut
and DA synthesis and neurotransmission. Likewise, the GTP cyclohydrolase Gch1 was identified as a marker
for DA-only neurons. Using a fluorescent in situ hybridization protocol, I validated these findings showing the
Slc26a7 marks DA+/Glut+ cells while Gch1 marks DA+/Glut- cells. I have shown unique induction of the neuronal
activity marker Fos in Slc26a7+ cells in the VTA 1 hour following cocaine, but not fentanyl, experience; this same
response was not observed in Gch1+ cells, suggesting a difference in response to cocaine between these two
distinct DA neuron populations. These results suggest that two subpopulations of DAergic cells in the VTA
respond to cocaine in unique ways and may in turn drive distinct downstream effects and behavioral responses
to cocaine. Following these findings, I hypothesize that differences in cellular targets and neurophysiology confer
distinct behavioral roles of DA subpopulations. Using these selective markers, I have designed and generated
novel adeno-associated viruses (AAVs) to both express distinct fluorophores and manipulate the neurons in a
cell-type specific way. Using these AAVs, this project aims to take a multidisciplinary approach to rigourously
investigate and determine any differences in cell types through the following aims: (1) Characterize
anatomical and cellular localization of projections, (2) Determine neurophysiological differences, and (3)
Determine the role of combinatorial cells in behavior. The proposed studies will deepen our understanding of the
role of these combinatorial cells in SUD, providing avenues for therapeutic exploration for a disease largely
lacking treatment options. Under this award, I will master behavioral paradigms and electrophysiology,
techniques that will aid my success as a physician-scientist.

Public health relevance
Project Narrative: Further exacerbated by the COVID-19 global pandemic, the rate of overdose related deaths has increased to over 107,000 in 2022. This proposal will investigate the role of dopamine and dopamine-glutamate combinatorial cells, cell types that have additionally been found in humans, within the rat mesolimbic dopamine pathway. This work will parcel out the role of these cell types in reward, cocaine use, and substance use disorder to pave the way for more targeted therapies and deeper comprehension of the complex interplay between the brain, behavior, and addiction.